Episodic Future Thinking to Improve Management of Type 2 Diabetes in Rural and Urban Patients: Remote Delivery and Outcomes Assessment to Increase Reach and Dissemination

This attachment is not required by the FOA; this placeholder is uploaded to resolve system errors.

Public health relevance
This attachment is not required by the FOA; this placeholder is uploaded to resolve system errors.